UNC Center for AIDS Research Core G Social and Behavioral

PROJECT SUMMARY/ABSTRACT – SOCIAL AND BEHAVIORAL SCIENCE (SBS) CORE (CORE G)
The Social and Behavioral Science Core facilitates the investigation of social, psychological, and structural
factors affecting the HIV epidemic by providing a broad spectrum of social and behavioral science research
services; mentoring junior investigators and investigators new to HIV research; and creating and strengthening
research partnerships through networking tools and events.
The Core is led by the Director, Dr. Carol Golin, Associate Director, Dr. Bill Zule, and Dr. Felicia Brown will be
joining the Core as an Assistant Director. The Core utilizes a unique staffing structure that incorporates the
diverse areas of expertise of Dr. Stuart Rennie (HIV biomedical ethics), Dr. David Rosen (epidemiology and
criminal justice research), Dr. Seth Noar (health communication), Dr. Vivian Go (implementation science), Steve
Bradley-Bull (Motivational Interviewing) and Eunice Okumu (Core Manager and mixed methods research). The
Core provides low-cost, easily accessible services to researchers at UNC and partner institutions including, but
not limited to, support for: design of research proposals and protocols; development of conceptual models;
development, implementation, and evaluation of theory-based interventions; and qualitative and quantitative
data collection and analysis. The Core also provides training in data collection methods, including semi-
structured, in-depth, and cognitive interviewing, focus group moderation, survey administration, and motivational
interviewing.
Through its biannual networking events, mentoring consultations, and networking directory, the Core brings
social scientists across disciplines together to work with biomedical researchers to conduct collaborative,
synergistic HIV prevention, treatment, and cure research. The Core will continue to work with partners at FHI
360, RTI International, NC-based HBCUs, other CFARs, and other UNC CFAR cores to strengthen and advance
innovative social and behavioral HIV research. The work of the Core will be guided by consultation with the Core
Directors, Core expert consultants, surveys of the CFAR membership, an Internal Advisory Board, an External
Advisory Board, and through discussions at CFAR retreats.